HEPARIN STRUCTURE STUDY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Heparin is well-known for its anticoagulant activity based on its ability to accelerate the rate at which antithrombin inhibits serine proteases in the blood coagulation cascade. Heparin is a linear polymer consisting of repeating units of 1[unreadable]4 linked pyranosyluronic acid and glucosamine residues and contains many sulfo groups that give it a high negative charge. NMR is a powerful technique capable of studying the structure of glycosaminoglycans without prior chemical or enzymatic cleavage into smaller oligosaccharides. Thus, NMR can be used to avoid the loss of structural information that results when the polysaccharides are broken down to smaller oligosaccharides. Here we performed proton and carbon 13 NMR to study the structure of heparin and the difference among different preparative lots.